2018 Chromatin Structure & Function Gordon Research Conference & Gordon Research Seminar

Project Summary/Abstract This proposal requests support for the 2018 GRC and GRS (partner conference for young investigators) meeting on Chromatin Structure & Function (focus on Chromatin encounters that shaping genome architecture and function) at the Jordan Hotel at Sunday River, Newry, ME, July 21-27, 2018. The entire genome is organized in as chromatin, with profound implications on all DNA-related processes in the cell. The 2018 on Chromatin Structure and Function will bring together leading experts and newcomers to the field, to present and discuss their newest research on chromatin, its complex interactions, and its regulatory power in shaping genome architecture and function. Technologies to visualize and map chromatin at all levels are proceeding at a rapid pace. The meeting will highlight how chromatin structures, ranging from the nucleosome ? the building block of chromatin - up to the dynamic three-dimensional spatial organization of the entire chromosome, are assembled, maintained, and altered, and how this ultimately controls genome functions. As such, the topic of this GRC/GRS is highly significant. Interconnected questions at the frontier of the field will be addressed ? how does the nucleosome interact with other nuclear factors, how is chromatin assembled, disassembled, and maintained in a dynamic state, what is the molecular basis for the crosstalk between epigenetic modifications and metabolism, and how does dysfunction of any of these processes resulting in disease. Presentations will encompass a wide variety of innovative technical approaches ? from Angstrom level description of chromatin components at all organizational levels to the visualization of micron-scale structures by light microscopy, and the mapping of chromatin states genome-wide at unprecedented resolution. There will be a focus on new methods to determine chromatin dynamics and the relationships between chromatin structure and function, and on adapting these to the level of single molecules and single cells. This conference has a long history of attracting the top researchers in chromatin research, and of bringing in `players' from related fields. It is an important forum for fostering new ideas, interactions and collaborations, and this tradition will be continued in 2018. We will continue to integrate new members into this growing field; a large number of talks will be reserved for young scientists and for under-represented minorities, and all applicants will have the opportunity to present a poster on their work. Additionally, `poster previews' will highlight selected posters in short oral presentations. Sufficient discussion time will be scheduled into every session to promote the lively and free exchange of ideas and interpretations and there will be ample time set aside in the afternoons and after the evening sessions for the informal interactions that have always played a key role at this conference. As a new feature this year, the GRC will be preceded by a GRS which we expect to further enhance interactions and networking among the younger conference participants.

Public health relevance
Project Narrative The organization of the entire genome in the form of intricately packaged supramolecular structures, collectively termed chromatin, has profound implications for all processes that require access to the information encoded in DNA. This GRC/GRS will bring together researchers with diverse backgrounds to discuss progress and breakthroughs in understanding how chromatin organization affects the readout of the genome, and how malfunction relates to human disease.